The impact of immune escape on the epidemiology and evolutionary dynamics of the COVID-19 pandemic in Yucatan, Mexico

PROJECT SUMMARY:
More than two years after the beginning of the COVID-19 pandemic caused by SARS-CoV-2, more
than 600 million cases and 6.5 million deaths have been reported worldwide. Genomic and
epidemiological analyses of SARS-CoV-2 have provided key understanding of the emergence and
evolutionary processes that drive viral mutations and promote antigenic escape and enhanced virus
transmission. Preliminary studies reported increased transmissibility for SARS-CoV-2 lineages with the
D614G mutation 1, as well as the variants of concern (VOC) Alpha/B.1.1.7, Beta/B.1.351, Gamma/P.1
and Delta/B.1.617.2. The emergence and unprecedented speed of transmission of the VOC
Omicron/B.1.1.529 resulted in a significant number of cases worldwide and breakthrough infections in
a high proportion of vaccinated individuals. Therefore, there is a continued need to monitor the genomic
characteristics of circulating viruses for early identification of new variants with altered immune,
transmission or pathogenicity properties, particularly in settings with high infection rates. Mexico ranks
third in Latin America in terms of COVID-19 burden with more than 7 million cases as of November 3,
2022, and third worldwide in total number of reported COVID-19 related deaths, with fatalities above
330,000. The COVID-19 pandemic has underlined the gaps in the current surveillance system in
Mexico. The genomic epidemiology of SARS-CoV-2 in Mexico is underrepresented and
undercharacterized due to limited spatial coverage of viral genomes. Genetic differences between
the circulating SARS-CoV-2 viruses in Mexico, the Americas and globally are unclear. Mexico is a vast
and diverse country with differences in demography, climate, and significant population mobility, both
domestically and internationally, recording 32.4 million US tourists in 2019 5. Our previous work on
influenza virus in Yucatan showed strong evidence that seasonality and the occurrence of genetic
variants vary greatly across the country, which encompasses temperate and tropical regions 6,7. Thus
examining the genomic epidemiology of SARS-CoV-2 in Mexico, particularly in highly touristic states
such as Yucatan, will shed light on the viral diversity and transmission dynamics in the country, and
clarify evolutionary changes as the disease becomes endemic. Because of tight connections between
Mexico and the US, these analyses will also contribute to informing public health interventions in both
nations.
This project leverages existing and newly generated data on SARS-CoV-2 in Yucatan and
consequently in Mexico, enabling: 1) epidemiological and mathematical modeling to evaluate
changes in viral dissemination and diversity in the context of vaccination campaigns and changes in
population mobility, and estimate the fitness advantage of new variants on a population level, and 2)
characterize circulating variants by generating genomic sequences and reconstructing the
evolutionary history and migrations that led to the emergence or introduction of locally circulating
lineages. Genomic and phylodynamic analysis, in conjunction with mathematical modeling, have
provided powerful tools to understand and predict the fate of new SARS-CoV-2 variants elsewhere 8.
An integrated capacity for outbreak analytics combining genomics, phylodynamics and
mathematical modeling is lacking in Yucatan, Mexico. This work will build local capacity to
address these questions and have a significant public health impact by providing accurate
information about COVID-19 transmission dynamics.

Public health relevance
PROJECT NARRATIVE Addressing the public health significance of SARS-CoV-2 requires a comprehensive analysis that includes genomics, phylodynamics and mathematical modeling of the epidemiological trends. Understanding the routes and mechanisms that lead to the emergence, seeding, and subsequent circulation of more transmissible or more pathogenic viral lineages will be crucial to guide local, national and international authorities in their response to COVID-19 pandemic.